Administrative Core

ADMINISTRATIVE CORE Project Summary: All research projects and Cores will benefit from the services provided by the Administrative Core. The Administrative Core will be responsible for the overall operation and coordination of the CLDRC, including both scientific and administrative activities. The Administrative Core will coordinate the ascertainment of all participants for the Research Projects, including the new clinic sample of 600 families and the follow-up assessments of participants from our previous twin studies. The Administrative Core will supervise procedures to recruit and retain mentees, monitor and mitigate known and emergent risks to all Center objectives, and evaluate the explicit benchmarks that will be used to measure the success of the Center. Finally, the Administrative Core will invite and coordinate the involvement of the External Scientific Advisory Board.